Targeting the Metabolome in Androgen Receptor-driven Castration-resistant Prostate Cancer

Alterations in metabolism especially lipogenesis are unique to prostate cancer progression and the changes
from benign to malignant prostate epithelium involves a switch from mitochondrial oxidative metabolism to
generate energy needs for cellular processes to aerobic glycolysis in cancer cells. This process is critical for
cell proliferation and new cell membrane synthesis including the continued proliferation driven by the androgen
receptor in most castration resistant prostate cancers (CRPC). Mechanisms driving these metabolic alterations
are not fully understood but the endogenous increase in endogenous lipogenesis by fatty acid synthase
(FASN), an androgen receptor driven gene, and a decrease in 5’AMP-activated kinase (AMPK) activity are
crucial components of the altered metabolic processes driving CRPC. In our Preliminary Data we demonstrate
that alteration in function of these two genes, inhibition of FASN and activation of AMPK, by two new drugs will
suppress growth of enzalutamide castrate resistant tumors in vitro and in vivo. We have shown that alteration
in metabolism will suppress the growth of tumors driven by AR constitutively active variants that were the basis
of my current VA Merit Review. The hypothesis of this project is that targeting activation of AMPK
suppresses PCa proliferation by regulating lipogenesis with subsequent inhibition of AR expression and
activity. In order to address this hypothesis we will first demonstrate expression of AMPK, AMPK-related
subunits (e.g., phospho serine 486, p-acetyl coenzyme A carboxylase), and FASN in tissue microarrays (TMA)
of primary prostate cancer, metastatic CRPC tumors, and prostate cancer patient-derived (PDX) models, and
determine correlation with AR, AR-V7, and AR-variants. We have previously shown a strong correlation
between FASN expression and AR in CRPC in metastatic prostate cancer. In addition, other studies have
shown activated AMPK levels decrease in progression from primary to metastatic prostate cancer and for
primary PCa, this may be predictive of development of metastatic disease. Therefore, we will examine use the
extensive patient material available in the University of Washington/Fred Hutchison prostate cancer program to
determine clinical expression of these cancer progression factors. Next we will determine the mechanism by
which AMPK is activated by BKI 1553 and affects AR transcriptional output. Our preliminary data indicates that
activation of AMPK by the dephosphorylation of Ser486 suppresses growth of AR-driven CRPC. Further, this
activity is activated by BKI 1553 but only in PCa cells that are AR positive. In this aim we will determine the
MOA of BKI 1553 activation of AMPK, potential target(s) and its subsequent mechanism of suppression of AR
expression and transcriptional activity. Next we will assess if antiproliferative actions of BKI 1553 include
transcriptional and post-transcriptional regulation of enzymes in monounsaturated fatty acids (MUSFAs)
metabolism. Finally, demonstrate in vivo activity of AMPK activation and FASN inhibition on CRPC. We will
expand to PCa PDX models identified in Aim 1 where FASN and/or AMPK expression has changed in
progression to CRPC in order to better show the applicability of BKI 1553 and IP1991 to a range of CRPCs.

Public health relevance
Prostate cancer is the most common solid tumor malignancy in our veterans’ population, with 13,000 veterans diagnosed annually. In addition, currently VA facilities are treating about 11,000 men with lethal metastatic castration resistant prostate cancer (CRPC). Developing pathways that could be co-targeted along with direct AR-targeting is a current translational and clinical priority, and a key focus of our work. Metabolic reprogramming to one that promotes disease progression, contributes to treatment resistance and leads to recurrent disease. This proposal will define the changes in metabolic reprograming that continue to drive disease progression through the androgen receptor signaling pathway. Importantly it will use two new and novel therapies we have developed to reprogram tumor metabolism and suppress androgen receptor expression and signaling and subsequent tumor growth in lethal prostate cancer.